Improving shared decision making in lung disease

PROJECT SUMMARY
Patients’ health expectations lie at the foundation of their preference-sensitive choices, such as whether to
pursue comfort-oriented therapies as a primary or concurrent strategy. To achieve high-quality shared decision
making, patients with serious illnesses must form accurate expectations for their future health. However, many
patients have inaccurate expectations, limiting their ability to make decisions concordant with their values.
Chronic obstructive pulmonary disease (COPD) is an incurable lung disease of older adults and a leading
cause of death worldwide. Patients with COPD and their caregivers frequently experience a high burden of
symptoms, mood disorders, and difficulty coping, yet underuse advance care planning and palliative
treatments. Existing evidence reveals that patients with COPD are at risk for expectation inaccuracies and our
preliminary work reveals that overly optimistic expectations are associated with worse quality of life over time.
Our overarching objective is to promote the well-being of patients living with COPD through the delivery of care
concordant with individual patients’ values. This work proposes a novel application of behavioral theories of
decision making and innovative methodologies to the common problem of goal-discordant care. This is a
prospective cohort study among 420 patients with severe COPD plus their family caregivers recruited from
Wake Forest Baptist Health, Geisinger Health System, and the University of Pennsylvania Health System.
These three health systems represent diverse communities, including rural and Black communities where
COPD is disproportionately burdensome, and have robust research infrastructures. The specific aims of this
study are to: 1) identify patient and caregiver characteristics associated with inaccurate health expectations, 2)
quantify associations between patients’ and caregivers’ expectation accuracy and well-being, and 3) identify
mechanisms through which clinician communication influences expectation accuracy.
The study team has the requisite content expertise, methodological expertise, and prior success conducting
investigations of this type. Completion of this project will provide mechanistic insights into ways to promote
optimal shared decision making in serious illness using state-of-the-art methods to test a novel conceptual
model. This work will result in key targets for intervention development to improve expectation management
and decision making among patients with serious illness.

Public health relevance
PROJECT NARRATIVE Over 16 million older Americans living with an incurable lung disease called chronic obstructive pulmonary disease report high levels of distress and poor quality of life. These patients and their informal caregivers make decisions based on the patients’ values and goals, relying on their expectations for the patient’s future health. This longitudinal project will provide critical information about the origins and impact of patients’ and caregivers’ expectations for patients’ future physical and emotional symptoms in order to improve shared decision making and quality of life for these patients and caregivers.